HARM-A: A neurobiological predictor of comorbidity and stress reactivity in anxiety disorders

PROJECT SUMMARY
Comorbidity in the anxiety disorders is common and strongly associated with poor outcomes, lower rates of
remission, increased disability and higher rates of relapse. Yet despite its clinical relevance, clinicians are unsure
how to treat comorbid anxiety patients, in part because it is unknown whether comorbid cases are marked by
distinct pathophysiology, or whether they should simply be conceptualized as the 'sum of their parts' (i.e.,
multiple, separate clinical entities). Characterizing comorbid individuals as having multiple, independent, disease
processes occludes understanding of synergistic, pathophysiological processes that may uniquely characterize
highly comorbid patients. The current project focuses on a neural profile that corresponds to increased
comorbidity load across the anxiety disorders and is routed in aberrant brain connectivity. This neural profile is
comprised of increased alarm (heightened amygdala) and reduced motivated attention (attenuated late positive
potential, LPP; an EEG measure of elaborated stimulus processing) to negative images, and is referred to as
HARM-A (Heightened Alarm, Reduced Motivated Attention). Controlling for separate effects of alarm and
motivated attention, preliminary data suggest that higher HARM-A is associated with (a) greater internalizing
psychopathology; (b) higher rates of past comorbidity (controlling for current comorbidity) and (c) increased
dysphoria 12-24 months later (controlling for baseline dysphoria). Those with higher HARM-A also showed
aberrant connectivity between key nodes involved in threat detection and appraisal (amygdala-anterior cingulate
cortex), as well as a stronger link between stress and negative affect. Therefore, HARM-A might underlie the
worse outcome in comorbid anxiety cases, and may do so by increasing risk for negative affect generation
following stressful events. The current project extends this preliminary work by examining negative emotion
processing in 180 individuals, recruited to insure dimensionality on current and past internalizing symptoms.
Participants will undergo 3 multi-level assessments (fMRI, EEG, clinical interview, self-report measures) over 24
months; at each assessment, participants will also complete 10 days of experience sampling assessments of
stressful events and negative affect. The project will test a bidirectional model of HARM-A, in which HARM-A
predicts increased future comorbidity load and higher scores on latent, transdiagnostic, internalizing
psychopathology, which will in turn predict increased HARM-A (i.e., a mutually reinforcing “spiral”). It will also
assess the neurocircuitry that supports higher HARM-A and will use experience sampling data to test whether
HARM-A predicts stronger linkage between stress exposure and subsequent negative affect. Finding that
HARM-A is prospectively and reciprocally associated with worse internalizing psychopathology, delineating its
neurocircuitry and elucidating its role in the linkage between stressors and negative affect would deliver a
mechanistic explanation for greater disease burden in comorbid anxiety and provide a path forward for more
etiologically tractable understanding of anxiety-related disorders, and for the development of targeted treatments.

Public health relevance
PROJECT NARRATIVE Comorbidity in anxiety disorders is common, exerts tremendous personal and societal costs, is difficult to treat and is associated with increased negative emotionality. Little is known about the neural mechanisms that promote anxiety comorbidity and negative emotionality. The current project focuses on a neural profile that corresponds to increased comorbidity load across the anxiety disorders and could lead to better ways to diagnose and treat the most burdened anxiety patients.